ONCOGENES (C-RAS) IN HUMAN CANCER INDUCTION

Harvey murine sarcoma virus (Ha-MuSV) and Kirsten murine sarcoma virus (Ki-MuSV) were isolated from rats inoculated with leukemia viruses of mouse origin. Both MuSVs induce pleomorphic sarcoma, splenomegaly, and erythroblastosis in rodents, and both MuSV DNAs are capable of inducing focal transformation in cultured mouse fibroblasts. Extensive characterization of the viral genomes has revealed that sequences from the rat genome have been incorporated and that these host-derived sequences are responsible for the viral tumorigenic potential. The viral oncogenes (called v-ras) encode similar but distinct 21,000 dalton phosphoproteins (p2ls). A closely related p2l is produced in normal cells. Using as probes cloned transforming gene sequences from Ha-MuSV (v-Ha-ras), and Ki-MuSV (v-Ki-ras). I have identified and molecularly cloned four different homologous DNA fragments (c-ras) from normal human cells. One of these normal human oncogenes can induce oncogenic transformation of rodent fibroblasts when this gene was ligated to a cloned viral control element. Transformants expressed elevated levels of p2l. Very recently, two difference human tumor oncogenes, isolated as transformation-competent sequences from tumor cell lines and tissues, have been shown to be homologous to two of our cloned normal human DNA genes. I propose to investigate the regulation of the expression of the normal human p2l homologues of Ha- or Ki-MuSVs and the relationship of these genes to human cancer. This investigation will include: 1) structural characterization of the four cloned human oncogenes (by DNA sequencing, restriction endonuclease mapping and heteroduplexing); 2) investigation of the tumorigenic potential of these genes (by ligation to promoterlike sequences and DNA-mediated transfer assay); 3) a search for other related but more divergent homologues of v-Ha-ras or v-Ki-ras in the human genome (by lowering hybridization stringency); 4) investigation of alterations in these genes in tumor tissue (by DNA sequencing, constructing chimeric clones between normal and tumor genes, and assessing their biological activity); and 5) examination of the expression of the human genes in normal and tumor cells (by probing mRNA with specific subclones representing each gene and immunoprecipitating newly synthesized protein with monoclonal antibodies specific for either Ha- or Ki-type p2l).